Arachnoid Granulation Senescence in Aging, CAA and Alzheimer's Disease

PROJECT SUMMARY/ABSTRACT
Arachnoid granulations (AG) are a unique tissue composite within the mammalian nervous system and are
known to enlarge with aging. Accumulating evidence suggest that AGs subserve specialized roles in glymphatic-
lymphatic drainage and may be a critical factor in brain resilience and diseases, including Alzheimer’s disease.
In spite of this, these meningeal structures have been poorly investigated across species. Historically, AGs have
been perceived to play a passive role in intracranial cerebrospinal fluid transport. Substantial gaps in knowledge
remain regarding their cell constituents and arrangement, and their associations with disease, due in large part
to lack of systematic and high-resolution microscopic analyses. To advance the field, better characterization of
AG structure is needed. In this study, we will use high-resolution microscopy techniques to elucidate the structure
of human AG and their morphological and compositional changes with aging. Their anatomy will be mapped
using immunohistochemical techniques and their features will be correlated with established neuropathological
and neurological measures of disease. For this work, we will leverage a rich resource of clinical and pathologic
material available from the Rush Religious Orders Study and Memory and Aging Project (ROSMAP) and will
collect and analyze novel data pertaining to the unique structure of AG. The hypothesis is that AGs function as
a critical neuroimmune tissue and that their senescence is associated with Alzheimer’s disease (AD). In Aim 1,
we will examine the associations of AG senescence with intracranial beta-amyloid (βA) accumulation and
pathology of AD. In Aim 2, we will examine the associations of AG senescence with clinically defined AD
dementia. In Aim 3, we will explore the role of apolipoprotein E genotype on the associations between AG
senescent features with intracranial βA load and cognition. In each aim, we will investigate how relationships
differ by age, clinical or pathological AD stage, sex, and comorbid diseases. Overall, these studies have the
potential to uncover new knowledge regarding the AG milieu in aging and AD as well as novel insights into the
person-specific nature of the glymphatic-lymphatic connection. The proposed investigations will advance the
field and may reveal mechanistic, diagnostic and prognostic factors for AD while laying a framework for studying
AGs in the setting of other age-related neurological diseases.

Public health relevance
PROJECT NARRATIVE Arachnoid granulations are situated at the human glymphatic-lymphatic interface and are hypothesized to have a pivotal but unexplored neuroimmune function and role in clearance of brain waste. To understand their broader impact on aging and disease, it is critical to elucidate arachnoid granulation senescence and its association with intracranial beta-amyloid accumulation and Alzheimer’s disease.